Validation of Quality Measures for Patient-Centered Cancer Communication in Rwanda

PROJECT SUMMARY/ABSTRACT
The burden of cancer is rising in Africa and mortality rates are high. A majority (70-80%) of patients present at
advanced stages, and cancer care incurs substantial financial costs for families and healthcare systems. Even
for potentially curable patients, effective treatment delivery is hampered by low adherence and retention in
care. In this context, patient-centered communication (PCC) offers an immediate opportunity to improve
treatment outcomes, optimize resource utilization, and alleviate suffering. PCC means responding to individual
patients’ perspectives and needs, involving patients in decision making, and providing emotional support.
Patients and clinicians in many African settings, including in Rwanda, have identified critical deficits in PCC
and have called for a cultural shift toward patient-centered care. Empowering patients through patient-reported
measures, and clinicians through communication skills training, has the potential for broadly impactful
improvements in PCC. A key barrier to progress in PCC research in African cancer care is the absence of
context-appropriate measures of communication quality. Currently, no measures of clinical communication
have been validated in an African cancer care context. This proposal addresses this gap by adapting,
validating, and piloting a patient survey of communication quality in Rwanda. Specifically, Dr. DeBoer aims to
(1) adapt an existing patient survey, the Patient-Centered Communication in Cancer Care (PCC-Ca), based on
input from Rwandan stakeholders; (2) establish psychometric properties of the adapted PCC patient survey in
Rwanda; and (3) conduct a feasibility pilot trial of the adapted PCC patient survey to evaluate a communication
training intervention for clinicians in Rwanda. To achieve these aims, Dr. DeBoer will leverage her existing
research partnership at Butaro Hospital in Rwanda and her prior work adapting a PCC clinician training
intervention for the Rwandan context. The proposed research will result in context-appropriate measures that
can be used to evaluate a PCC clinician training intervention in a future R01 cluster randomized trial in
Rwanda. This K08 award will support advanced training in implementation science and career development in
global oncology, organized around four training goals: (1) stakeholder-engaged research; (2) program
evaluation; (3) interventional trial design; and (4) career development in global oncology. For each goal, Dr.
DeBoer will complete coursework, fulfilling the UCSF Certificate in Implementation Science, as well as
mentored tutorials and experiential learning from research aims. An exceptional multidisciplinary team of
mentors with an optimal balance of complementary expertise will guide Dr. DeBoer in achieving her goals. This
training will position Dr. DeBoer for a successful independent research career as an implementation scientist
and leader in the emerging academic field of global oncology, advancing Dr. DeBoer’s ultimate objective of
promoting global cancer equity by improving the quality of care for patients in East Africa and beyond.
1

Public health relevance
PROJECT NARRATIVE As oncology capacity expands in sub-Saharan African countries such as Rwanda, implementation research is needed to improve the quality of patient-centered communication between clinicians and patients with cancer. The objective of this proposal is to develop patient-reported measures of communication quality that are appropriate for the Rwandan context and can be used to empower patients and clinicians to improve communication. Ultimately, a shift toward patient-centered care has the potential to improve cancer treatment outcomes, optimize resource utilization, mitigate clinician distress, and alleviate patient and family suffering. 1